Dendrite development, function, degeneration and regeneration

Project Summary/Abstract
Since 2002, a major focus of our lab has been dendrite development. Dendrite arborization patterns are critical
components of neural circuits; they influence the synaptic or sensory inputs a neuron receives. Back in 2002,
little was known about the molecular mechanisms that control dendrite development. To use Drosophila
genetics to identify core programs that control dendrite development, we first showed that the larval dendritic
arborization (da) neurons, a group of sensory neurons, are well suited for this purpose. They can be divided
into four classes based on their class-specific dendritic morphology. By using this system, we have identified
and studied many genes that control neuronal type specific dendritic morphology, the size of dendritic arbor,
and how different neurons organize their dendrites relative to one another. Many of the molecular mechanisms
that control dendrite development originally discovered in Drosophila are conserved in mammals. Given that
dendrite defects are associated with neurological disorders such as Down’s syndrome and a subset of autism
spectrum disorder, elucidating molecular mechanisms that control dendrite development is not only important
in basic neuroscience but also could contribute to potential future treatments of neurological disorders.
Building on our previous findings, we continue to explore three related research areas: (1) Elucidating the
mechanisms that control dendrite development. We are keen to identify the tiling signal that mediates the
mutual repulsion of the dendrites of adjacent c4da neurons, so the dendrites of those neurons form a regular
array without overlap. We are using the cell surface proximity labeling technique developed by our collaborator
Dr. Jiefu Li to characterize cell surface proteomes of da neurons to identify the tiling signal. (2) Studying
mechano-sensation exhibited by Drosophila da neurons. All da neurons are mechano-sensitive (MS),
prompting us to ask how MS channels work: (a) The gating mechanism of NOMPC. We have demonstrated
that NOMPC is a bona fide MS channel with its 29 Ankyrin repeats (ARs) and the pre-S1 linker acting as
tethers that convey forces from microtubules to gate the channel. We are collaborating with Dr. Yongli Zhang
and Dr. Yifan Cheng to use optic tweezers and cryo-EM to study the mechanical properties and the gating
mechanism of NOMPC. (b) The physiological function of MS channels. We are particularly keen about
pursuing our recent discovery that dOSCA is an intrinsic mechano-sensor of the lysosome and dOSCA mutant
flies exhibit impaired lysosome-mediated degradation, synaptic loss and progressive motor deficits. (3)
Uncovering mechanisms underlying dendrite and axon regeneration after injury. Why do different types
of neurons differ in their ability to regenerate their axon or dendrite after injury? What factors can enhance or
inhibit regeneration? We find da neurons to be an excellent system to study these problems. Recently, we
discovered novel roles of MS channels (Piezo and dOSCA) in axon regeneration and neurodegeneration –
exciting findings bringing a confluence of our interests in neuron degeneration/regeneration and MS channels.

Public health relevance
Narrative This project aims to discover the cellular and molecular mechanisms that control dendritic development, degeneration, and regeneration. Having found that many of the dendrites we studied are mechano-sensitive, we have strived to elucidate how mechano-sensitive ion channels including NOMPC and OSCA channels work and what physiological functions they fulfil. Given that dendritic defects are the likely cause of many neurological disorders such as autism, Down’s syndrome, and certain neurodegenerative diseases, this project may contribute to the diagnosis and potential treatment of such neurological disorders in the future.